Perinatal care as a venue to reduce opioid overdoses and hepatitis C virus incidence (PreVenT OD HCV)

PROJECT SUMMARY/ABSTRACT
Amidst the current opioid overdose crisis, 1.4 million women of reproductive age report non-medical opioid
use, and opioid use disorder (OUD) prevalence among pregnant women quadrupled from 1998-2014. Although
pregnancy may be a motivating time to start medications to treat OUD, retention post-partum declines
significantly and is associated with unacceptably high opioid overdose and mortality rates. Injection drug use is
also the primary risk factor for hepatitis C virus (HCV) infection in the United States (U.S.). Women now
comprise nearly half of new HCV infections, and HCV seroprevalence has risen five-fold in pregnant women
since 2000. Although the U.S. is committed to eliminating HCV, about 50% of people are unaware of their
infection and fewer than 40% of those diagnosed have been treated. Research is needed to identify venues
to increase efforts to improve OUD treatment and retention and to identify and treat current HCV
infection. Perinatal care provides longitudinal access to women over a nearly one-year period, and as
pregnancy may be a motivating time for women to seek care for both OUD and HCV, perinatal care may
be a critical venue to reach women who inject drugs, a key population that NIDA identifies as central to
the ongoing opioid crisis. Yet, little data exist to measure the role of the perinatal care venue to improve
OUD and HCV care engagement. This study aims to create a perinatal-specific decision model and measure
health service utilization and costs of a perinatal OUD and HCV intervention to identify how to leverage the
perinatal care venue to decrease postpartum opioid overdoses and population-level HCV transmission. This
study has two main aims: (1) to build a microsimulation model to analyze the clinical and health economic
effects of leveraging the perinatal care venue to reduce opioid overdoses and population-level and infant HCV
transmission; (2) to measure health services utilization and costs of incorporating MOUD and HCV treatment
into perinatal care. The results of this study could help determine most efficient resource allocation to achieve
national overdose and HCV elimination goals. The PI, Dr. Epstein, is an early career investigator, trained in
pediatric and adult infectious diseases, with a focus on addiction medicine and HCV in pregnant women and
youth. This career development award will allow her to gain expertise in 1) transmission modeling and model
calibration and 2) health economic evaluation and micro-costing to be able to conduct comparative cost-
effectiveness research to inform interventions for women with substance use and HCV. She has compiled an
experienced team of mentors and advisors to help her achieve her training and career goals, to become an
independent clinician-investigator expert in utilizing decision science to project most effective use of resources
to improve care for families at the center of the opioid overdose, HCV and HIV epidemics.

Public health relevance
PROJECT NARRATIVE As opioid use disorder (OUD) and hepatitis C virus (HCV) infection prevalence continue to rise in the United States, particularly among young women, new strategies are needed to identify high-impact venues to address both epidemics together. Pregnancy is a motivating time for women to engage in care for both their own health and that of their families. This project will utilize programmatic and public health data and simulation modeling to project the clinical and cost-effectiveness of employing interventions in the perinatal care venue to reduce opioid-related mortality and HCV transmission.